Graduate Training in Demography

SUMMARY
We are requesting continuation of the NICHD training grant in Demography to the University of Pennsylvania
(Penn). The proposed program continues Penn’s longstanding excellence in training in Demography, as per
placement of, and scientific contributions by, trainees. It will be enhanced during the upcoming cycle by (a)
new engagement of population researchers from the Health Policy Division of the Department of Medical
Ethics & Health Policy at the Perelman School of Medicine; (b) a major reorganization of the training sequence
in demographic methods; (c) new integrated training in the areas of biomarkers, complex data structures, data
science, and quantitative methods; (d) new exchange training programs with two prominent European
research centers (Max Planck Institute for Demographic Research and French Institute for Demographic
Research); (e) expanded activities to enhance diversity. Six predoctoral positions (no postdoctoral positions)
are requested. The principal aim of the Demography predoctoral program at Penn is to train independent
researchers who are prepared to play leading roles in population analysis. This goal is achieved through
(i) intensive instruction in the methods, theoretical approaches, and empirical substance of demography and
allied disciplines; (ii) progressive incorporation of students into faculty research activities; and (iii) subsequent
branching into independent research. The training in Demography described in this proposal reflects a vision
of the population sciences and population health in which a strong background in the logic of demographic
process is the gateway to the application of contributions from elsewhere in the social and behavioral sciences
to an array of topics of public and scientific interest.

Public health relevance
NARRATIVE The principal aims of the Training Program in Demography at the University of Pennsylvania accord with the NICHD Population Dynamics Branch’s (PDB) mission to support research and research training in demography, reproductive health, and population health. In particular, training in demography as proposed in this application is essential for research on morbidity and mortality, COVID-19, HIV/AIDS, fertility, families, population movement, and population composition that is central to the PDB mission. The Training Program in Demography at Penn builds on a strong faculty, dedicated students, and an impressive group of alumni to maintain its ongoing relevance to the mission of NICHD, which is “to understand human development, improve reproductive health, enhance the lives of children and adolescents, and optimize abilities for all.”